A Novel Recombinant Protein for Mitigating Acute Radiation Injury

PROJECT DESCRIPTION: This SBIR Phase II proposal is intended to further develop recombinant human
MFG-E8 (rhMFG-E8) as a radiation medical countermeasure (MCM) towards its approval by the FDA in the
future. Nuclear terrorism and major nuclear power plant leaks can cause acute radiation injury on a large
scale. Currently, there are limited drugs available to treat acute radiation syndrome (ARS). rhMFG-E8 is a
secretory glycoprotein that can maintain intestinal barrier homeostasis, enhance the clearance of dying cells,
and reduce inflammation. In our Phase I studies, we have shown that endogenous MFG-E8 is downregulated
after radiation injury, and treatment with E. coli-expressed His-tagged rhMFG-E8 improved the survival, body
weight, and intestinal integrity of rats exposed to gamma irradiation. However, E. coli-expressed His-tagged
proteins are inappropriate for the use in humans. Therefore, we have generated tag-free rhMFG-E8 using
human cells, significantly enhancing rhMFG-E8’s biological activities. We have shown that tag-free rhMFG-E8
significantly improved the survival, body weight, and intestinal integrity of mice exposed to X-ray irradiation.
We also determined rhMFG-E8’s pharmacokinetics, possible lack of mutagenicity, and short-term (3 months)
stability. Based on the above positive results, we hypothesize that human cell-expressed tag-free rhMFG-E8
can be developed as an effective and safe post-exposure mitigator of acute radiation injury. In this proposal,
we will assess tag-free rhMFG-E8’s efficacy as a radiation MCM in mice with the gastrointestinal acute
radiation syndrome (GI-ARS) and hematopoietic acute radiation syndrome (H-ARS). In addition, we will
determine the therapeutic window and effects of reduced treatment duration after radiation exposure, as well
as rhMFG-E8’s safety and potential oncogenicity and immunogenicity. These proposed studies should provide
crucial information on the efficacy and safety of rhMFG-E8 as a novel radiation MCM targeting GI-ARS and
combined GI- and H-ARS. Our ultimate goal is to obtain FDA approval to use rhMFG-E8 as a safe and
effective treatment for victims suffering from severe ARS.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT: Radioactive exposure related to disasters, accidents, terrorism, or war can cause acute radiation injury in a vast scale. The gastrointestinal acute radiation syndrome is a particularly deadly form of acute radiation injury for which there is no FDA-approved treatment. We have shown that rhMFG-E8, a protein found in human milk, improves gut injury caused by radiation, and will further develop rhMFG-E8 towards its future approval by the FDA and procurement by the US Strategic National Stockpile Program.